Defining the signaling pathways that direct adult tissue stem cells to exit multipotency

Adult stem cells can give rise to entire tissues and this regenerative ability is essential both for repairing
tissues after injury, and for maintaining tissues throughout life. Given their important role in normal biology,
aging, and disease, there is significant interest in defining the signaling networks that direct stem cell fate.
While prior research has identified key regulators of mammary stem/progenitor cell biology, many regulators
have yet to be identified, and how these various regulators function within signaling and transcriptional
networks to modulate mammary stem/progenitor fate remains poorly understood.
Our long-term goal is to define how the internal circuitry of stem/progenitor cells integrates external
signals to regulate their fate. We study mammary tissue because of its unique advantages as an experimental
model, and because this tissue undergoes multiple cycles of expansion and regression throughout life --
exemplifying the importance of stem cells in adult tissues. This study will contribute essential new knowledge
of the signaling networks that regulate stem cell biology by defining a new link between two known regulators
of stem cell fate (RUNX1, NOTCH), and by identifying a novel kinase (DDR1) that was previously not known to
regulate mammary stem cell fate. The specific objectives of this project are to define how two key
regulators, RUNX1 and NOTCH, cooperate to drive the lineage specification of mammary stem/progenitor cells
(Aim 1), and to establish how a novel regulator, DDR1, promotes the differentiation of mammary stem and
progenitor cells (Aim 2). We will address these objectives with two specific aims:
(1) Define the RUNX1- and NOTCH-regulated transcriptional network that drives mammary
stem/progenitor differentiation.
(2) Define the signaling network activated by DDR1 to regulate stem/progenitor cell differentiation.
This study will contribute public health by identifying new genes and signaling networks that regulate
stem cell fate in adult tissues, which will facilitate the development of new therapies that harness the power of
stem cells for regenerative medicine. This study is experimentally innovative in how it leverages our
recently developed hydrogel cultures for growing patient-derived mammary tissues, in synergistic combination
with cutting edge genomic approaches – including CRISPR and single-cell profiling – to dissect the
transcriptional networks and signaling cascades that regulate stem/progenitor fate in human mammary tissue.
In summary, these investigations will contribute to our fundamental understanding of how adult stem cell
differentiation is genetically controlled, and will yield important knowledge that will be necessary to fully
harness the power of adult stem cells for regenerative medicines.

Public health relevance
Adult stem cells exhibit a regenerative ability that is critical for maintaining tissue homeostasis throughout life, and for repairing tissues after injury. Leveraging these unique cells for regenerative therapies will require a detailed understanding of the genetic networks that regulate their self-renewal and differentiation, which are currently poorly understood. This study will address this gap in our knowledge by defining new genes and signaling networks that are important regulators of stem cell fate in adult issues.